Core C: Community Collaborative Core

PROJECT SUMMARY / ABSTRACT
The COBRE for Stress, Trauma, and Resilience (STAR) will establish a transformative, transdisciplinary
Miriam Hospital research center focused on the biobehavioral mechanisms through which childhood stress,
trauma, and adversity impact health outcomes across development. Childhood adversity is a major risk factor
for physical and mental health problems across the lifespan, yet those with adverse exposures are highly likely
to be underserved due to socioeconomic position. Children and adults from disadvantaged backgrounds,
including racial and ethnic minorities, individuals living in poverty, and sexual minority and gender diverse
populations are at substantially heightened risk of exposure to adversity. Further, although disadvantaged
communities are most likely to experience adversity and trauma, they are often difficult to reach and engage in
research as a result of societal discrimination, medical mistrust, marginalization, stigma, and economic and
structural factors. Specialized infrastructure to address the practical, ethical, and clinical issues in research
with vulnerable and underserved populations is critical for long-term success of the STAR COBRE. The
Human Subjects and Vulnerable Populations (VP) Core will support the overall goals of the STAR
COBRE by building critical infrastructure to support clinically significant and highly innovative
research with vulnerable children and adults with stress and trauma histories. In addition, because all
three proposed research projects in this COBRE include data and biospecimens from human subjects, the VP
Core will serve as a recommended hub for documentation and training related to human subjects’
protection for all components of the COBRE (PAR-19-313). The VP Core will provide resources and
support targeted to developing capacity to successfully recruit and retain difficult to reach populations,
while maintaining to standards in the ethical conduct of research with children and adults with stress and
trauma histories. The VP Core will also provide support to enhance existing and build new community
partnerships, and to increase competence of COBRE faculty and staff regarding issues of diversity, equity,
and inclusion. The VP Core will be essential to the overall success of the STAR COBRE by providing critical
expertise, services, and infrastructure to support clinically significant and highly innovative research with
vulnerable children and adults with stress and trauma histories.